iACTIVATE: Investigators Advancing via Coaching at the Transition to Independence: a Value-Adding Team Experience

PROJECT SUMMARY
Gender inequities are prevalent and persistent in the biomedical sciences. While women and men are equally
likely to enter medicine, women are less likely to advance in terms of promotion and leadership. The effects are
significant as women are less likely than men to publish as first/last authors, receive awards, and serve on
study sections—all critical measures for advancement. These workforce inequities have worsened over the
past 18 months as faculty have been adversely affected during the COVID-19 pandemic. Studies show these
disruptions have negative impacted career trajectory and productivity, with early career investigators, females,
and underrepresented in medicine groups most significantly affected. Early career faculty, including those at
pivotal points in their trajectory such as transitioning to independence, are more vulnerable to the pandemic’s
effects due to fewer established funding sources and publishing opportunities. Interventions are needed to
reduce these pandemic-related effects and thereby minimize worsening of inequities long-term. Coaching, a
practice commonly utilized in business and management, holds potential to be a high-impact intervention for
early career investigators. Coaching applies inquiry, encouragement, and accountability to increase self-
awareness, motivation, and the capacity to take effective action. The current literature on coaching in medicine
suggests benefits for clinicians and administrators in terms of process metrics largely. Few studies have
focused on investigators, combined individual and group coaching with customized feedback, or examined
productivity and advancement outcomes. This randomized controlled trial aims to evaluate a professional
coaching intervention directed at early career investigators. Participants will include individuals with a K-level or
equivalent award who self-identify as female or nonbinary, with efforts made to maximize diversity in the study.
This novel intervention is based on principles of social cognitive career theory, and content is aligned with
researcher competencies and informed by early career researchers. Outcomes focus on established hallmarks
of success for faculty investigators, including self-efficacy, research productivity, and career advancement
obtained through surveys (Aim 1 and 2). These data will be combined with interviews to fully capture the
impact of the coaching program by understanding nuanced individual experiences (Aim 1) and experiential
sampling method to examine the mechanism by which the program fosters research productivity and career
persistence (Aim 3). Results from this study will provide rigorous evidence about the effect of a novel, theory-
based coaching intervention on female early-career investigators while offering a scalable approach that can
be readily adopted by academic institutions and professional organizations. Dissemination will be supported by
the development of a train-the-coach guide and coaching program toolkit. Such interventions are vital to
increase the proportion of underrepresented scientists who persist in the biomedical research workforce in
order to address the health needs of the nation’s diverse population.

Public health relevance
PROJECT NARRATIVE Gender inequities are prevalent and persistent in the biomedical sciences, and workforce inequities have worsened over the past 18 months as the COVID-19 pandemic has disproportionately impacted on female, minority, and early career investigators. To reduce pandemic-related effects and minimize worsening inequities long-term, we propose a randomized study to evaluate a novel, scalable, and theory-based professional coaching intervention called iACTIVATE directed at early career female investigators. We will test whether this coaching program can lead to improved self-efficacy, research productivity, and career advancement as well as examine potential mechanisms for outcomes; if successful, the novel program will be ready to scale to the broader biomedical research workforce nationally.